Heterogeneous immune responses of the alveolar macrophage population during pulmonary fungal infections

PROJECT SUMMARY/ABSTRACT
Alveolar macrophages (AMs) are lung-resident macrophages. They are one of the cell types that first
encounter inhaled fungal pathogens. Currently, the role of AMs in fungal infections is still elusive; some articles
reported AMs to be protective, but others showed them detrimental. The challenge to study AMs is that
identification and evaluation of AMs in vivo require technologies such as; multi-color flow cytometry, reporter and
fate-mapping (FM) mouse systems, and single cell-level of gene expression analyses. By using these
technologies, we will elucidate the biological functions of AMs during pulmonary fungal infections.
We recently demonstrated that AMs are the bona fide immune sentinels that respond to fungal infections
and also elicit heterogeneous immune responses. In particular, fungal infections generate pro- and anti-
inflammatory AM subpopulations simultaneously, and AM subpopulations with distinct functions co-exist in the
infected lung. Such heterogeneity within the AM population cannot be elicited by pulmonary instillation of Toll-
like recent ligands, suggesting possible specificity in fungal infections, likely through C-tyle lectin receptor
signaling.
The central hypothesis of this proposed study is: AMs develop into pro- and anti-inflammatory AMs in
vivo at the level of transcriptional and epigenetic regulations, respectively. The generation of AM subpopulations
with dichotomous functions is considered to maximize fungal clearance and minimize collateral damage in the
lung. The objective of this proposed study is to identify the biological implication of functionally distinct AM
subpopulations and to elucidate the detailed molecular mechanism by which the heterogeneous AM
subpopulations are generated, maintained, and lost during fungal infections in vivo.

Public health relevance
PROJECT NARRATIVE Patients with pulmonary fungal infections suffer both from the infection itself and lung tissue damages caused by overshooting antifungal immune responses. We recently discovered that alveolar macrophages (AMs) develop functionally distinct subpopulations upon fungal infections. Understanding the basic mechanism of how hosts keep an optimal balance of the immune responses is critical to developing new therapeutic approaches fungal infections.